Training Grant in Diabetes, Endocrinology and Metabolism

This application is for the renewal of a post-doctoral training grant at the University of Minnesota in
diabetes, endocrinology, and metabolism that has been in existence since 1977. The need for this
training program has never been greater. Diabetes, obesity, and other endocrine diseases now affect
more than half of the United States population but the number of research scientists committed to this
area of investigation of has not kept pace with the growth in disease prevalence. The long-standing
goal of this program has been to prepare physicians and graduates of PhD programs for successful
research careers in academic medicine. This preparation has been centered upon the critical
interaction between the trainee and the research mentor. All mentors in this program have national or
international reputations in their respective areas and have strong track records in mentoring. Their
efforts are supported by a strong administrative structure that encourages trainees to be deliberate in
obtaining the skills they will need to become independent investigators. This structure also regularly
evaluates and monitors the success of the trainee and the overall program as well as supports the
development of a highly interactive relationship between the trainee and mentor. The particular
research strengths of our faculty include cellular metabolism and genetics; endocrinology and signaling;
neurobiology and appetite regulation of obesity; stem cell biology, autoimmunity, and β-cell biology; and
clinical aspects of endocrine disease. Applicants for this program come from leading Universities and
Medical Schools from around the world. Our trainees have all either completed a residency program in
internal medicine in the United States or received a PhD in a biological science at a major research
University before enrolling in this fellowship. In this application, we request an increase in the number
of our post-doctoral fellowship positions from three to four each year so we can support more PhD
trained scientists interested in endocrinology as a career while continuing our long standing
commitment to training physician scientists. These positions will be used to provide support for 2 MD
trained and 2 PhD trained post-doctoral fellows selected for their outstanding potential to become
leading scientists in diabetes, endocrinology, and metabolism each budget year.

Public health relevance
This research training program will prepare physician and PhD trained post-doctoral fellows to become investigators in the area of diabetes, endocrinology, and metabolism. We are experiencing an epidemic of diabetes and obesity worldwide, and in the United States, more than half of the population may be affected by these endocrine/metabolic diseases. Our public health demands that talented scientists determine why these diseases occur and develop new ways to prevent and treat them; as a result of the education and training obtained in this program, our fellows will be prepared to address these problems and improve the public health.